BLR&D Research Career Scientist Award Application

70 million Americans suffer from some sort of sleep disorder. Behavior, mood and memory deteriorate
with sleep loss and it gets worse with continuing sleep deprivation. Sleep disturbance is a frequent and
common complaint among our Veterans. Lack of sleep due to hyperarousal is one symptom of PTSD, but it is
not known why Veterans with PTSD cannot fall asleep. My research focuses on identifying and mapping the
brain neurons that induce sleep. The overall impact of my research is that it will provide the first direct
evidence linking specific phenotypes of neurons and their circuits responsible for inducing sleep. This will make
it possible to induce sleep in conditions where the arousal drive is very strong, such as in the insomnia of
PTSD, or to maintain wakefulness when there is excessive sleepiness, such as in patients with obstructive
sleep apnea or atypical depression.
One series of experiments uses optogenetics and pharmacogenetics to identify functional circuits in the
brain. The brain contains many different types of cells and through optogenetics and pharmacogenetics it is
now possible to disassemble the brain to identify the culprit neurons responsible for complex behaviors, such
as sleep. My lab was the first in the area of sleep neurobiology to use optogenetics to induce sleep
(Konadhode et al., 2013, attached). We activated a specific phenotype of neurons in the hypothalamus and
discovered that it induced sleep at a time of day when the mouse should have been awake. We have now
shown the same effect in rats, indicating that activating these neurons drives sleep across mammals. We now
want to test the sleep-inducing effect in conditions of high arousal, such as fear-conditioning (PTSD) or anxiety.
In conjunction with optogenetics and pharmacogenetics, I am using the deep-brain imaging method to
image the activity of phenotype-specific neurons in the brains. This method measures changes in
fluorescence of a genetically encoded calcium indicator in individual neurons. The fluorescence signal is
captured via a microendoscope attached to a miniature microscope (2g). The microendoscope can be placed
anywhere in the brains of mice providing unprecedented record of neuronal activity. I am using it to obtain
visual evidence of the activity of specific neuronal circuits during sleep and waking.
Another series of studies uses the CLARITY method to map the circuit activated by optogenetics.
CLARITY is a new neuroanatomical method that makes postmortem tissue, such as the brain, transparent.
The PI collaborated with RHJVAMC researchers to acquire a Zeiss Lightsheet microscope and used it to
produce a 3D reconstruction of brain neuronal circuits (see Shiromani and Peever, 2017 attached). My intent is
to use CLARITY to visualize postmortem brains in rodent models of TBI, and also image a transparent heart,
liver and kidney. The goal is to provide a visual record of the break in a circuit in diseased tissue.
The fourth series of experiments use the gene transfer approach to fix defective circuits and restore
behavior. I have used it to successfully to correct behavioral symptoms in a mouse model of the
neurodegenerative sleep disorder, narcolepsy. We are now using the gene transfer method to block triggering
of abnormal behavior, for example in fear-conditioning. Overall, these neuroscience methods and tools aid the
collective research effort at RHJ VAMC.

Public health relevance
Sleep disturbance is a frequent and common complaint among our Veterans and within the general population. Veterans suffering from post-traumatic stress disorder (PTSD) and depression have severe sleep disorders. In PTSD, there is a marked hyperarousal that makes it difficult for patients to fall asleep. The cause of the insomnia in PTSD is not known because we do not have a clear understanding of the brain circuits that induce sleep. I am using new genetically engineered tools such as optogenetics, pharmacogenetics, deep-brain imaging and CLARITY to identify the brain circuits responsible for specific behaviors, such as sleep. My laboratory is actively engaged in mapping neural circuits, and training a new generation of scientists in the use of cutting-edge neuroscience tools and methods.